Task Order No.HHSN26100076 Understanding the Role of Muscle and Body Composition on Cancer Risk and Prognosis in Cancer Survivors - Meeting Support

Understanding the Role of Muscle and Body Composition on Cancer Risk and Prognosis in Cancer Survivors - Meeting Support